FENTANYL, LIDOCAINE, AND KERTOROLAC IN POST-MASTECTOMY PAIN SYNDROME

The pain syndrome following breast cancer surgery is at present poorly understood, and without tested therapies except for physical therapy and topical capsaicin. The purpose of this study is to: 1) characterize the sensory and motor function abnormalities associated with post-mastectomy pain, and 2) pharmacologically explore potential therapies by comparing IV fentanyl (opioid), lidocaine (Na channel blocker), and ketorolac (potent NSAID) with saline placebo in a double-blind, randomized, 4 session study.